Identifying and reducing stigmatizing language in home healthcare: the ENGAGE study

Project Summary/Abstract
Nurses are the largest sector of health providers in the United States (US). Recent studies have found
widespread biases among nurses, with the most common bias being in the area of race and ethnicity. Nurses'
biases affect treatment decisions, thereby affecting patient outcomes. Nurses' biases are especially critical in
settings where nurses are the main provider of healthcare services, such as home healthcare (HHC) where
nurses visit more than 5 million patients in their homes across the US every year. Racial biases are reflected in
medical documentation; in hospital settings, clinical notes about Black patients have up to 50% higher odds of
containing stigmatizing language (i.e., language that negatively characterizes patients) than White patients'
notes. In the HHC setting, we also found that clinical notes of Black and Hispanic patients had up to 20%
higher odds of including stigmatizing language than White and Asian patients. Critically, our studies found that
stigmatizing language in the clinical notes is associated with negative clinicians' attitudes and lower quality of
patient care.
One promising technology—natural language processing (NLP)—has the potential to help uncover
stigmatizing language in millions of HHC nursing notes. In collaboration with two of the largest providers of
HHC services in the US (Louisiana Health Care Group and VNS Health, with more than 100,000 patients on
the combined daily census), this study assembles an interdisciplinary team of experts in HHC nursing, NLP,
and clinical decision support to build the first step in designing a nurse-centered NLP-based system to rEduce
stigmatiziNG languAGE ("ENGAGE") via the following specific aims. Aim 1: Expand and refine the ontology of
stigmatizing language applicable to HHC. Aim 2: Determine the optimal NLP approach to automatically and
accurately identify stigmatizing language in the clinical notes of geographically dispersed HHC agencies. Aim
3: Compare the prevalence of stigmatizing language by race and ethnicity. Aim 4: Develop an NLP-driven
ENGAGE system to reduce stigmatizing language in HHC clinical notes.
Accomplishing these aims will result in ENGAGE- a technology-driven behavior change intervention
that will help to identify and eliminate racial biases among HHC nurses.

Public health relevance
Project Narrative Nurses often use stigmatizing and racially-biased language in clinical documentation, which results in poor quality of care for minority patients. This project aims to design and pilot-test a technology-driven system, ENGAGE, that will help to identify and reduce the use of stigmatizing language among home healthcare nurses. Achieving this goal will reduce racial biases and improve the quality of care for patients treated in home healthcare settings.